Architecture of a divergent bipartite internal ribosome entry site from Giardiavirus

Project summary
Translation initiation is the most regulated step in protein synthesis. In eukaryotes, canonical
translation initiation begins with recognition of a cap structure on the mRNA 5’ end, and is a very
complex process requiring many protein factors and intermediates. To favor translation of their own
proteins, RNA viruses have evolved simpler ways to initiate protein synthesis. One such viral tool is an
internal RNA entry site, or IRES, a structured RNA that drives noncanonical, cap-independent
translation. Some IRES elements show great promise, either as new targets for therapies directed
against pathogenic RNA viruses, or as tools for optimizing protein expression in mRNA-based
vaccines.
The three-dimensional IRES structures determined to date have come almost exclusively from just two
of the many IRES classes. More structures of diverse IRES elements are needed to determine
existing IRES mechanisms, and ultimately to lay the groundwork for the development of improved
IRES tools for novel therapies. Despite their significant structural and mechanistic differences, almost
all IRES elements share one notable feature: little if any of the IRES is located in the coding region.
Remarkably, a IRES from Giardia lamblia virus (GLV) violates this paradigm. The GLV IRES is
bipartite, with one canonical domain 5’ to the start codon, and a second large, highly structured
domain located entirely in its coding region. The secondary and three-dimensional structures of the
GLV IRES are unknown. We propose to determine the architecture of the GLV IRES bound to its host
ribosome. This work will provide foundational knowledge about the role of an unexplored class of
IRES domain in viral infection of a human pathogen, Giardia lamblia. Giardiasis is the most common
parasitic human diarrheal disease worldwide, and an increasingly serious neglected disease. Our
results will pave the way for long-term studies of this divergent IRES mechanism, and potentially
reveal pathways that can be targeted in diverse viruses, helping the long-term goal of developing new
therapies for one of the world’s leading intestinal diseases.

Public health relevance
NARRATIVE The GLV IRES is a viral RNA structure that reprograms protein synthesis in the neglected human parasite Giardia lamblia. We propose to determine the three-dimensional structure of the GLV IRES bound to the Giardia ribosome with the goals of (1) understanding how this highly divergent, two- domain RNA machinery works, and (2) laying the groundwork for future studies.